Post-transcriptional regulation of gene Expression during bone regeneration.

Abstract
Co-transcriptional and post-transcriptional mechanisms play central roles in regulating gene expression.
Understanding how these mechanisms control gene expression and, thus, cellular homeostasis is essential for
the development of novel therapeutic approaches. Splicing is a co-transcriptional process during which introns
are removed from pre-mRNAs and the remaining exons are connected. Connecting the exons in different
combinations is called alternative splicing (AS), a process that generates diversified mature mRNAs from the
same gene. AS plays crucial roles in regulating gene expression, and mis-splicing is implicated in different
diseases. Thus, AS is a tightly regulated process. In spite of its well-established roles, AS is understudied in
the context of fracture healing.
Proteoglycan 4 (PRG4) is an extracellular matrix protein found throughout the animal kingdom and is
best known for its lubricant effects in articular cartilage. PRG4 is highly expressed in the synovial fluid and
possesses chondroprotective effects; therefore, exogenous expression of recombinant PRG4 in the articular
cartilage halts the progression of osteoarthritis. PRG4 is also expressed in organs other than articular joints,
including the liver, heart, and bone. However, the biological functions of PRG4 in these tissues are not well
defined. Importantly, the expression pattern and biological functions of PRG4 during fracture healing have
never been characterized.
Our preliminary data indicate high expression of Prg4 in the callus periosteal stem cells (PSC) during
the inflammatory phase of fracture healing. Interestingly, Prg4 is predominantly expressed in callus PSC as a
splice variant that lacks 3 coding exons and has bever been reported in any musculoskeletal tissue. This splice
variant is conserved in human cells. TGFB1 significantly induces Prg4 expression and reprograms Prg4
splicing, which makes Prg4 expression and splicing pattern in the callus PSC distinct from those in the intact-
bone PSC. Inhibiting the expression of Prg4 in the callus results in reduced abundance of PSC, defective soft-
callus formation, and reduced callus mineralization and bone formation. Thus, we hypothesize that Prg4
undergoes a unique splicing pattern in the callus that is mediated, at least in part, by TGFB1, resulting in a
splice variant that plays critical autocrine and paracrine regulatory roles and impacts different healing phases.
In Aim 1, we will assess the roles of the Prg4 splice variant in different healing phases and in
maintaining the homeostasis of different cell types in the callus. In Aim 2, we will study the autocrine effects of
PRG4 and how it regulates the homeostasis and differentiation of PSC. In Aim 3, we will identify the molecular
pathways that regulate Prg4 expression and splicing, define the unique roles of different splice variants of Prg4
in regulating PSC and human BMSC homeostasis, and determine the receptors via which Prg4 signals.
Completion of our studies will bridge several knowledge gaps and identify novel roles of PRG4 in bone repair.

Public health relevance
Project Narrative We are witnessing a new era of RNA therapeutics that is expected to introduce novel therapeutic approaches to the pharmaceutical market. Designing an RNA-based therapeutic requires comprehensive understanding of gene expression and how it is regulated, an area that requires more attention in the field of fracture healing. Completion of the studies proposed in this R01 application is expected to define novel roles of alternative splicing in generating a callus-specific splice variant of proteoglycan-4 gene, which plays crucial roles in promoting bone regeneration.